Impact of neurofibromin on ER-alpha and nuclear speck post-transcriptional gene regulation

PROJECT SUMMARY
Alternative splicing (AS) of transcripts is an essential post-transcriptional process that is instrumental
for numerous cell functions including proliferation, differentiation, and survival. The process of AS is regulated
by RNA binding proteins (RBPs) and their proper nuclear localization and interactions with spliceosome
components which form visibly dense compartments called nuclear specks (NS). The ability for cancer to
hijack and utilize AS by targeting genes involved in EMT, invasion, cell cycle regulation, and transcriptional
control has been described to influence metastatic potential and therapeutic resistance. More recently, it has
been shown that 50% of breast cancers contain overexpression or amplification of at least one RBP which
consequently targets gene transcripts for AS to induce invasive characteristics. Furthermore, a novel function
of estrogen receptor alpha (ERα) recently revealed non-canonical RNA binding of ERα to influence post-
transcriptional regulation and promote cell fitness in response to environmental stressors. Our laboratory,
along with other, recently established a critical link between NF1 and ERα in regulation of ERα signaling. NF1
is a tumor suppressor gene, encoding for the protein neurofibromin, that when mutated drives of a subset of
breast cancers with poor prognosis. These studies have sparked motivation to investigate mechanisms in
which NF1-deficient breast cancers contribute to metastasis and endocrine resistance.
The interaction between neurofibromin and ERα describes neurofibromins ability to act as a co-
repressor of ERα’s transcriptional activity. However, it still remains unknown whether this neurofibromin-ERα
interaction regulates ERα’s post-transcriptional regulation or the importance of neurofibromin localization for
this regulation. The overall goal of my F99 training phase (Aim 1) is to determine the role neurofibromin plays
in ERα post-transcriptional regulation. Specifically, the Aims are 1.1) to define neurofibromin’s impact on ERα
dependent post-transcriptional regulation in NF1 mutant ER+ breast cancer models and 1.2) determine the
efficacy of selective estrogen receptor modulators (SERMs) to impact ERα post-transcriptional regulation in
NF1-deficient cells. The training objectives in the F99 phase will expand my molecular techniques, sequencing,
and data analysis in cancer biology. During my K00 phase (Aim 2) I will define the impact nuclear
neurofibromin has on post-transcriptional regulation through nuclear speck formation and function. NF1-
deficient breast cancer models will be used to determine nuclear speck formation, composition, and post-
transcriptional and gene regulation. The training and data resulting from this fellowship award will establish the
foundation of scientific and professional skills for my career as an independent researcher.

Public health relevance
PROJECT NARRATIVE Germline and sporadic loss of function mutations in the tumor suppressor gene, NF1, drives a subset of breast cancer with increased metastatic potential, endocrine resistance, and dismal outcomes in disease. Here, I propose to study the mechanisms in which loss of neurofibromin-ERα interaction contributes to this aggressive subtype of breast cancers in order to identify tractable therapeutic options while receiving new training in next generation sequencing and analysis along with comprehensive analysis of cancer datasets. In the next phase of my career I will build upon this foundation of knowledge to expand my discoveries in identifying novel functions of NF1 and its role in cancer progression.